The role of unobserved cholera: implications for prevention and control

ABSTRACT
Surveillance of many human pathogens relies primarily on clinical diagnosis of individuals who seek testing or
care. In most contexts the number of unobserved infections is unknown, which poses a challenge in effectively
mitigating transmission. Infections may go unobserved for a number of reasons, including mild and
asymptomatic infections not captured by clinical surveillance as well as symptomatic infections not captured
due to factors such as barriers in access to healthcare or limited testing resources. This is true for Vibrio
cholerae, a pathogen responsible for an estimated 3 million cholera cases and 100,000 deaths each year.
Previous studies in Bangladesh have shown that unobserved infections account for at least half of V. cholerae
infections and that individuals with asymptomatic infection shed less V. cholerae in their stool compared to
symptomatic cholera. The extent to which this impacts our ability to prevent and control outbreaks, and
whether these findings apply to other populations, is unknown. In this study we aim to address this gap in our
knowledge by investigating the contribution of unobserved infections to cholera burden and transmission in
multiple populations. We propose to do this by estimating the magnitude of V. cholerae infections that go
unobserved by comparing patterns in clinical and serological data across various endemic and epidemic
locations (aim 1), examining the degree to which individuals with mild symptoms who commonly go
unobserved shed V. cholerae bacteria that may be transmitted (aim 2), and estimating the risk of infection
following exposure to asymptomatic household contacts (aim 3). We expect to find high levels of unobserved
infections, particularly in areas with barriers in access to healthcare. We also anticipate that mild/asymptomatic
infections will be associated with bacterial shedding and ongoing transmission, but to a lesser extent than
cases with more severe symptoms. Alternatively, since people with mild/asymptomatic infections are less likely
to receive antibiotics and often continue to go about their daily routines, we may find increased bacterial
shedding and secondary infections in these cases. In either scenario, these results will provide important
insights into the degree to which unobserved infections contribute to V. cholerae persistence and spread, as
well as their role in our efforts to mitigate outbreaks. Our long-term goal is to better understand the underlying
host, microbial, and socio-demographic factors that lead to infections going unobserved so that we can design
more effective prevention and control strategies.

Public health relevance
PROJECT NARRATIVE Cholera surveillance and control strategies rely primarily on detecting symptomatic cases that seek care; mild infections and infections in individuals with barriers in access to healthcare are often unobserved. This project aims to examine the degree to which unobserved infections contribute to the burden and transmission of Vibrio cholerae. The approaches used in this study are relevant to a broad range of infectious diseases and will lay the groundwork for addressing critical questions about the host, microbial, and socio-demographic factors that contribute to infections going unobserved, ultimately leading to more effective mitigation strategies.